Regulation of Energy Homeostasis by FGF21

Project Summary / Abstract
Obesity is a major contributor to the epidemic of metabolic diseases including dyslipidemia, cardiovascular
disease, and type II diabetes. Numerous studies suggest that increasing energy expenditure can effectively
decrease body weight. However, no current therapeutic compounds safely or selectively activate energy
expenditure. The endocrine hormone fibroblast growth factor 21 (FGF21) decreases body weight during
obesity by increasing energy expenditure without affecting physical activity. Moreover, FGF21 potently
decreases both fat and body mass in obese animals and human patients. However, the mechanism for
FGF21-mediated increases in energy expenditure has not been identified. Work from our lab and others have
demonstrated that FGF21 acts in the central nervous system to promote weight loss. In addition, several lines
of evidence suggest that FGF21 requires intact signaling from the adipose-derived hormone, leptin, to elicit its
full effects on driving weight loss. Finally, our preliminary data demonstrates that the obligate FGF21 co-
receptor, β-klotho, is expressed in the arcuate nucleus (ARC) and ventromedial hypothalamus (VMH), primary
sites of leptin action in the brain, and that leptin activates signaling in β-klotho-expressing cells in the VMH and
ARC. Thus, we hypothesize that FGF21 signals, at least in part, to leptin-sensitive cells in the VMH and/or
ARC to modulate energy expenditure. This proposal employs novel genetic mouse models, chemogenetic
manipulation of neurons, and pharmacological approaches to investigate the crosstalk between FGF21 and
leptin signaling in the central control of energy homeostasis. Through these studies we aim to identify novel
therapeutic targets for the treatment of obesity and obesity-associated disorders.

Public health relevance
Project Narrative The proposed research aims at understanding a novel hormonal pathway that regulates body weight and metabolic flexibility with the ultimate goal to develop new treatments for obesity and obesity-associated diseases. Specifically, this proposal examines endocrine crosstalk between leptin and FGF21 signaling and evaluates the contribution of leptin signaling in the energy expending effects of FGF21.